Network of the National Library of Medicine Region 1

For over 35 years, the University of Maryland, Baltimore (UMB) Health Sciences & Human Services Library (HS/HSL) has exemplified innovation, relevance, and far-reaching advancement of access to health information and data as the Regional Medical Library (RML) of the Network of the National Library of Medicine (NNLM), Southeastern Atlantic Region. As the Region 1 RML for the 2021-2026 Cooperative Agreement, the RML Team proposes an ambitious program that includes engagement, funding, and training opportunities for all network members. Done in tandem with responsive health, data and digital literacy programming the RML Team expands the reach and impact of the National Library of Medicine (NLM) for all populations and audiences and advances the mission of the NNLM. The RML Team incorporates community-driven health outreach in the Region to bring quality health, public health, cultural and environmental health, and biomedical information resources and data within the easy to reach of the public, researchers, health professionals, public health workforce, and educators by:
• Cultivating synergistic partnerships within a governance and advisory structure for Region 1 that advances the vision, strategies, and standards of NNLM.
• Developing a strong workforce of trusted ambassadors to advance access to NLM biomedical health information resources and data-driven research to all audiences.
• Applying innovative, community-driven approaches and interventions to promote awareness of, access to, and use of authoritative NLM resources and data sets to develop a strong healthcare workforce.
• Continually evaluating and improving the effectiveness, impact, and value of the RML program to develop replicable outreach services and programs that are responsive to measures of effectiveness.
Thinking nationally and acting regionally, the RML Team is eager to serve as the new Region 1 RML leading innovative initiatives in support of the development of a strong workforce and health and digital access for all.

Public health relevance
Overall Core Project Narrative at the Region 1 RML for the 2021-2026 Cooperative Agreement, the University of Maryland, Baltimore (UMB) proposes an ambitious program that includes training, funding and engagement opportunities for all NNLM members. Done in tandem with responsive health, data, and digital literacy programming, the reach and impact of the National Library of Medicine (NLM) expands for all populations and audiences and advances the mission of the Network of the National Library of Medicine (NNLM). Thinking nationally and acting regionally, the RML Team applies research and replicable community-driven programs to improve and increase access to quality health information, for all.